Core B Modeling Core

PROJECT ABSTRACT
The goals of the COBRE Center for Applied Immunology and Pathological Processes (CAIPP) are to establish
a nationally recognized advanced research and training program to understand immunological contributions in
various disease states and facilitate the development of junior faculty research programs to achieve major
independent research funding. Application of networking analysis and modeling approaches to immunological
questions is capable of predicting genetic mediators and modeling immune outcomes in response to various
pathogens and disease states. The Center for Applied Immunology and Pathological Processes proposes to
develop a Modeling Core (Core B) to support the CAIPP research activities. The goals of the Modeling Core are
to provide access to technical and scientific expertise that advances individual COBRE investigator projects. The
Modeling Core will bring needed infrastructure to drive hypotheses, expedite publications, and enhance our
competitiveness for extramural funding. Education and training initiatives will increase the systems-based
bioinformatics knowledge at LSUHSC-S and inspire others to pursue bioinformatics in their research.